Cancer Prevention and Control Research Program

CANCER PREVENTION AND CONTROL PROGRAM: PROJECT SUMMARY
The Virginia Commonwealth University (VCU) Massey Cancer Center (MCC) first introduced its Cancer
Prevention and Control (CPC) Program within the Cancer Center Support Grant (CCSG) in 1991. The CPC
Program has matured into a highly multidisciplinary nexus of investigators, including population health as well
as clinical and basic scientists, and the program continues its emphasis on identifying and mitigating cancer
risks. However, since the last CCSG renewal, the CPC Program has recruited multiple new experts in
survivorship research, further expanding its impact across the cancer care continuum. The Program is highly
focused on addressing MCC’s and the community’s priority disease concerns – lung, gastrointestinal, breast,
and prostate cancers – as well as two lifestyles or behaviors significantly driving the cancer burden (tobacco
control and obesity prevention). CPC research aligns well with the MCC’s Community-to-Bench framework and
its mission, goals, and strategic plans, and the program leads Center efforts actively engaging the community in
research. Furthermore, the Center-wide emphasis on reducing disparities is exemplified by many CPC members’
efforts to understand and address inequities among racial/ethnic as well as rural/urban communities, and notably
where the two intersect. For instance, within MCC’s catchment area, it is the rural Virginia communities with
majority-minority populations of Blacks/African Americans being reported among the nation’s cancer hot spots.
Led by Oxana G. Palesh, PhD and Victoria J. Findley PhD, the CPC Program comprises 44 scientists
representing 12 departments across the Schools of Medicine, Pharmacy, and the College of Humanities and
Science. The program has $6.8M in annual, direct, peer-reviewed funding ($2.5M from NCI, $3.1M from other
NIH institutes; and $1.2 from other agencies). In the current project period, CPC members authored 337 cancer-
focused research publications reflecting the highly collaborative nature of these scientists; 125 (37%) were intra-
programmatic, 46 (14%) were inter-programmatic, 233 (69%) were inter-institutional with 161 (48%) being
collaborations with other NCI-designated cancer centers. In addition, the CPC Program has tripled the number
of multi-Principal Investigator (MPI) and multi-project awards during the current project period. Their portfolio
now includes 16 MPI R01/R21s, two U01s, one UG1, one U54, two P20s, and a Stand Up to Cancer award. The
CPC Program also has a growing portfolio of clinic- and community-based interventional studies addressing
disparities, supportive care needs, and survivorship, and investigators and since 2016 have enrolled 1,663
individuals to interventional studies and over 18,000 to non-interventional studies. During the next CCSG project
period, the CPC Program will continue to anchor its efforts around community-based and community-engaged
research to identify and decrease cancer risks, increase cancer screening, and reduce disparate cancer
outcomes and inequities for all patients.